DUCTUS ARTERIOSUS STENT TO IMPROVE CONGENITAL HEART DEFECT MORTALITY

ABSTRACT
The technical challenges faced by pediatric cardiovascular physicians (surgeons and interventionalists alike)
have long been ignored, forcing them to use devices designed for adults and different conditions to treat ailing
babies with very specific anatomical considerations. One such case is in the sustained opening of the ductus
arteriosus, a natural conduit that exists in all newborns but closes shortly after birth. In certain congenital heart
defects, it is crucial to maintain ductus patency for the newborn to survive without surgical intervention. There is
no ductus arteriosus stent commercially available in the US. Pediatric interventional cardiologists currently
repurpose adult stents for the ductus, and all-cause ductus reintervention is 47%. The alternative is open-chest
surgery on a neonate to place a shunt that carries a 13% risk of morbidity and 7% risk of mortality, even in the
United States. Starlight Cardiovascular has created a ductus arteriosus stent that is specifically designed to
address the challenges facing treating physicians, including a right-sized delivery system, end-to-end coverage
of the ductus, navigation and deployment through tortuous ductus anatomy, and precise placement to avoid
stent protrusion into the aorta and pulmonary arteries. A stent designed and tested specifically for this purpose
has the potential to decrease reinterventions, morbidity, and potentially mortality for babies with ductal-
dependent circulation. The feasibility of the innovative stent system designed for pediatric applications using
self-expanding technology has been demonstrated, and a Phase II SBIR is underway to complete the formal
preclinical testing of the device. This Phase IIB SBIR application proposes undertaking a clinical trial that will
support FDA approval. A single arm study of forty infants with congenital heart disease and ductal dependent
circulation will be enrolled in the trial at up to ten sites. Subjects will be followed for 180 days or until their planned
second surgery. Results of primary safety and efficacy outcome measures will be obtained and compared
against predetermined performance goals. This Phase IIB project will determine the safety and efficacy of the
ductus arteriosus stent system. If the trial is successful, Starlight Cardiovascular will seek FDA approval and
commercialization of the first ductus arteriosus stent in the United States.

Public health relevance
PROJECT NARRATIVE One percent of babies are born each year with Congenital Heart Disease (CHD), and these babies often require surgical intervention to survive. However, the devices that are currently used to treat this pediatric population were designed for adult cardiovascular conditions and do not always perform as intended in babies. Starlight Cardiovascular aims to solve this problem by developing a portfolio of devices for CHD, starting with what will be the first FDA-approved ductus arteriosus stent, which has the potential to save lives and increase access to less invasive treatments for babies born with CHD.